Pilot Project Program

ABSTRACT
The goal of the Pilot Project Program is to support the mission of the Centers of Biomedical Research
Excellence (COBRE) Center for Molecular Epidemiology at Dartmouth, to advance transformative discoveries
to reduce the burden of human disease and develop future leaders in the field. To date, the Pilot Project
Program has supported 15 pilot projects led by early-stage, mid-career, and senior investigators that have
contributed to the Center themes of i) applying new scientific discoveries and technologies to address major
health concerns, ii) identifying early indicators of disease pathogenesis, and iii) exploring common pathways of
disease etiology and progression in human populations, including those related to health inequities. Pilot
Project Leaders have published 326 peer-reviewed manuscripts and received 52 extramural grants as
Principal Investigators, totaling $85.8 million dollars. Building on the success of our work in Phases I and II,
and by incorporating feedback from external advisors and previous pilot awardees, we propose to enhance the
Pilot Project Program in Phase III to accelerate the career trajectories to scientific discovery and extramural
support of talented scientists in the field of molecular epidemiology. Applicants will be solicited through multiple
media and channels for three funding opportunities: 1) new and early-stage investigator projects to expedite
career development and research independence; 2) multi-PI projects that promote multi-disciplinary team
science leading to larger program and center grants; and 3) multi-institution projects that strengthen
collaborations with partnering IDeA states. We will encourage applicants from underrepresented groups and
facilitate research that addresses the health of vulnerable populations, considers biological sex as potential
modifier of disease risk, and benefits from the Center’s state-of-the-art Biorepository and Biospecimen
Resource Facility Core. We also will allow for a fast-track mechanism of time-sensitive, high-risk, high-reward
applications. A letter of intent will be requested to screen for eligibility and permit pre-application mentoring.
Applications will be ranked by a review panel using the criteria and processes of NIH study sections, followed
by funding recommendations by the External Advisory Committee prior to submission to the NIH for final
approval. Post-award mentorship and holistic career development offerings will be tailored to the Pilot Leaders’
goals, scientific focus, and career stage. Opportunities will be responsive to member surveys and guidance
from the Steering and Advisory Committees. Thus, our strategy will provide Pilot Leaders with the necessary
preliminary data, mentorship, and training to compete for multiple grant mechanisms, and to grow impactful
independent and collaborative research programs in molecular epidemiology.